Role of a Novel Secreted Protein Tyrosine Kinase in Development

DESCRIPTION (provided by applicant): The microenvironment in which cells reside in tissues, the extracellular matrix (ECM), is increasingly recognized as a major regulator of embryonic morphogenesis. We propose to use the Xenopus embryo as a model system to study a novel mechanism of regulation of ECM, the tyrosine phosphorylation of secreted proteins. In our preliminary experiments, we have identified a protein tyrosine kinase that, unlike any previously known tyrosine kinase, is synthesized directly into the secretory pathway, and which phosphorylates extracellular matrix proteins. Our preliminary data indicate that this novel kinase as a key role in early craniofacial patterning. The activity and location of this kinase provides the first explanation for a large body of published phosphoproteomic work reporting conserved tyrosine phosphorylations in ECM proteins secreted via the canonical signal peptide pathway. We plan to use frog embryos to study the function of this secreted tyrosine kinase in early craniofacial morphogenesis, and identify and characterize tyrosine phosphorylated substrates in an in vivo context. These studies will provide the basis for an entirely new area of study, the reversible regulation of secreted proteins by tyrosine phosphorylation during embryogenesis. Dynamic regulation and remodeling of ECM is also central to a wide range of disease pathologies (e.g. tumor metastasis, fibrosis, atherosclerosis), and therefore the regulation of ECM proteins by tyrosine phosphorylation is likely to also have important implications for the modulation of disease pathogenesis.

Public health relevance
PUBLIC HEALTH RELEVANCE: We plan to study a newly identified mechanism of regulation of the extracellular environment during embryonic development. We are particularly interested in how this novel regulatory mechanism underlies the early establishment of craniofacial structure.